Genetic Epidemiology of Non-Renal Diabetic Complications

In the current project, genetic determinants of non-renal complications of diabetes and related traits are being sought using techniques of genetic linkage and association analysis. (For a report on renal complications see Genetic Epidemiology of Diabetic Nephropathy Z01 DK069094.) Lymphoblast cell lines have been established from informative pedigrees. DNA is available from other families in nuclear pellets extracted from blood specimens obtained in the epidemiologic studies. Families with many diabetic members have been ascertained through the epidemiologic studies and most have participated in studies of genetics of diabetes or nephropathy (see also Genetic Epidemiology of Diabetes and Obesity Z01 DK069028). Some families have been studied in collaboration with the multicenter Family Investigation of Nephropathy and Diabetes (FIND). Genome-wide linkage studies of total cholesterol levels in the Pimas have identified strong evidence for linkage on chromosome 19p.[unreadable] [unreadable] In the past year the heritability of diabetic retinopathy was assessed in individuals who participated in the multicenter Family Investigation of Nephropathy and Diabetes (FIND), in collaboration with FIND investigators; severe retinopathy was moderately heritable. We have also begun to assess candidate genes for retinopathy in a region on chromosome 1p that was linked to diabetic retinopathy in our genome-wide linkage scan. [unreadable] [unreadable] Current studies involve systematic surveys of candidate genes in the chromosome 19p region linked to total cholesterol levels. Periodontitis has also been assessed in these pedigrees and linkage analyses are currently being conducted. Genetic variants implicated in retinopathy in genome-wide association studies in type 1 diabetes are also being assessed for their association in type 2 diabetes.